Development and Pilot Test of a Clinical Swallowing Examination (CSE) Protocol for Telerehabilitaion Delivery of SLP Services

Purpose: The overarching goal of this study is to improve access to timely clinical swallowing
examination (CSE) and dysphagia treatment in veterans with stroke. The purpose of this study
is to establish a CSE protocol (CSEP) that can be used for speech-language pathology (SLP)
telerehabilitation services, Significance: A timely CSE is critical to prevent dysphagia related
mortality, morbidity, prolonged length of hospitalization, and increased healthcare costs. Delays
in SLP services will occur when stroke patients present after business hours, on weekends or
during holidays. Telerehabilitation for SLP services has great potential to eliminate all access
barriers in dysphagia assessment and management for stroke survivors. Specific Aims: The
study will address 3 specific aims: 1) Develop/refine a CSEP for tele-SLP practice using the
Mann Assessment of Swallowing Ability (MASA) with input from a multidisciplinary team of
SLPs, stroke ward nurses, and telestroke consultants; 2) Establish preliminary inter-rater
reliability between a tele-SLP administering and scoring the MASA via mHealth technology with
bedside nurse facilitation, versus an on-site SLP simultaneously and independently scoring the
MASA; and 3) Pilot the tele-SLP CSEP within a VA NTSP facility to refine mHealth delivery
processes and to establish feasibility, acceptability, recruitment strategies and outcome
measurements for ‘timely CSE services. Methods: This is an exploratory study using both
qualitative and quantitative methods. The study will be conducted at the Michael E. DeBakey VA
Medical Center, with virtual partners at the VA National TeleStroke Program facility in
Murfreesboro, Tennessee. Participant will include SLPs (N=3), registered nurses (N=20) and
veterans (N=55) admitted with stroke. Data Collection/Analysis Procedures: The CSEP for tele-
SLP practice will be developed using the MASA, the only validated, standardized CSE for stroke
patients. Iterative simulation and debrief methods will be applied to establish and document
optimal techniques for mHealth delivery of each MASA item. Basic content analysis will be
applied to code debrief session notes and observations. Once a CSEP for tele-SLP practice is
established, a tele-SLP and a nurse facilitator, at the patient’s bedside, will complete the CSEP
on veterans admitted with stroke (N=50). An on-site SLP will also be at the bedside and will
make simultaneous but independent clinical judgements concerning patient responses to all
MASA questions/tasks using the operational definitions provided by the MASA. Preliminary
inter-rater reliability will be established between a tele-SLP administering and scoring the MASA
via mHealth technology with bedside nurse facilitation and an on-site SLP simultaneously and
independently scoring the MASA. Cohen’s weighted kappa will be calculated for each MASA
item including dysphagia risk, aspiration risk, as well as recommendations for diet and
instrumental assessment. Iterative refinement of the CSEP will continue to achieve moderate to
strong agreement for all items of the MASA. Simultaneous to establishing preliminary reliability
of the CSEP, mHealth delivery processes will be iteratively developed and refined. In
preparation for a larger implementation study, the CSEP will be pilot tested in veterans (N=5)
admitted with stroke in a VA NTSP facility. Feasibility/acceptability of the CSEP will be
established among SLPs, nurses and patients using semi-structured interviews/questionnaires.
Successful recruitment strategies will be documented and measurement of timely tele-SLP
services will be determined via chart review.

Public health relevance
Swallowing problems are a major source of disability for stroke survivors affecting quality of life, nutrition, hydration, and pulmonary status. This project addresses an important need to improve access to speech language pathology (SLP) services for timely clinical swallowing examination (CSE) in patients admitted with stroke. With the emergence of mHealth (use of mobile wireless technology in health care), innovative hospital- based tele-SLP services are possible and have great potential to increase timely stroke telerehabilitation services for dysphagia. The evidence supporting the clinical accuracy and reliability of conducting a CSE via tele-SLP services is just emerging and the reliability of a CSE using mHealth technology is unknown. The investigators propose to develop, refine and pilot a CSE protocol for tele-SLP services using mHealth technology. Findings from this pilot project will inform a larger multi-site study to fully test mHealth strategies to improve access to tele-SLP services in patients with stroke.